Lipin-1 transcriptional coregulatory activity promotes macrophage pro-resolving response

Despite medical advances, atherosclerotic cardiovascular disease (ACVD) is a leading cause of death. ACVD is
caused by chronic inflammatory due to both excessive inflammation and failed inflammation resolution. Unlike
inhibition of inflammation that reduces ACVD but increases fatal infections, restoration of inflammation resolution
may reduce ACVD without increased fatal infections. Macrophages resolve inflammation by secreting anti-in-
flammatory mediators and phagocytosing dead cells in a process termed efferocytosis. Efferocytosis increases
intracellular free fatty acids (FA) that must be processed either through β-oxidation, incorporation in glycerolipids
or ceramides. The movement of FA into these different pathways is called lipid channeling. Increased β-oxidation
is associated with macrophage resolution and is considered atheroprotective, while ceramide metabolism pro-
motes inflammation and is considered atherogenic. However, there are several critical questions: 1) Is one path-
way more critical to inflammation resolution than the other, 2) does the alteration of one lipid pathway alter the
other, 3) how lipid channeling is regulated during resolution and plaque regression. Lipin-1 is a phosphatidic acid
phosphatase with transcriptional coregulatory activity. My laboratory showed that macrophage-associated lipin-
1 is needed for inflammation resolution and atherosclerotic regression and likely does this through regulation of
FA metabolism, independent of its enzymatic activity. Our central hypothesis is that lipin-1 is a dominant lipid
channeling regulator in macrophages, promoting inflammation resolution and atherosclerosis regression by en-
hancing β-oxidation and repressing ceramide synthesis. We will test our central hypothesis and accomplish the
objective of this application by pursuing three specific aims. Aim 1 will explore the hypothesis that lipin-1 regu-
lates the activity of metabolic transcription factors to fine-tune FA metabolic pathways to align with macrophage
resolution activity. Aim 2 will examine which FA pathways (FA metabolism, β-oxidation, or ceramide metabolism)
are critical to macrophage inflammation resolution response and find if the alteration in one pathway impacts the
others. Aim 3 will explore the hypothesis that lipin-1 non-enzymatic activity promotes atherosclerotic regression
and map the FA metabolic state of the regressing plaque. These proposed experiments will support the innova-
tive idea that lipin-1 in macrophages is a dominant regulator of lipid channeling and promotes inflammation
resolution by enhancing beta-oxidation while repressing ceramide synthesis. This application's beneficial impact
will be the understanding that fatty acid metabolism is regulated to limit lipotoxicity and promote inflammation
resolution to identify therapeutic targets to reduce the burden of atherosclerosis and its pathologic sequelae.

Public health relevance
The proposed research seeks a better understanding of the underpinnings of macrophages responses that promote plaque progression, plaques instability, and plaque regression that causes catastrophic cardiovascular disease. We can leverage this knowledge to develop novel, innovative technologies to reduce cardiovascular disease burden in America.